Peripheral nerve stimulation for activation of dopaminergic nuclei

PROJECT SUMMARY/ABSTRACT
The vagus nerves are important carriers of appetitive and nutritive information from the viscera to the central
nervous system (CNS). New studies are revealing surprising and striking differences between left and right
vagal-CNS connectivity. In particular, it was recently shown that activation of ascending gut projections through
the right, but not left, vagus nerve may activate classical dopaminergic “reward” circuits in the CNS. These recent
findings raise the intriguing possibility that electrical vagus nerve stimulation (VNS) delivered to the right cervical
nerve, rather than the traditionally-targeted left cervical nerve, could be used to modulate activity within these
reward networks, providing novel strategies for the treatment of movement disorders. However, both left and
right vagal fibers branch extensively in the periphery and carry information from the gut as well as liver, pancreas,
and other organs that may convey potentially rewarding nutritive or metabolic information. Additional research is
thus needed to fully understand the functional and translational relevance of lateralized vagal signaling.
Understanding whether and how lateralized vagal stimulation differentially activates reward networks is crucial
for further clinical development of this therapeutic technology. Left cervical VNS is currently FDA approved for
the treatment of epilepsy and major depressive disorders, and is rapidly emerging as a treatment to promote
weight loss, extinction of drug seeking, and motor rehabilitation after neural injuries. Importantly, the
effectiveness of VNS over this expanded set of therapeutic indications depends on optimal activation of the
dopaminergic pathways known to support reward-related reinforcement of learned behaviors. Thus, targeted
modulation of these pathways could provide additional mechanisms to induce therapeutic neuroplasticity within
the motor system. Delivery of VNS to the right cervical nerve may therefore offer additional benefits compared
to traditional left VNS for the treatment of motor dysfunction arising from, e.g., Parkinson's disease or stroke.
While evidence of strong laterality in vagal-midbrain connectivity is emerging, the extent to which right versus
left VNS evokes differential activation of central reward networks has not been systematically tested. Here, we
propose to comprehensively compare the dose-dependence of right vs. left VNS-driven midbrain activity, and to
test the functional relevance of lateralized VNS-driven dopaminergic signaling for the induction of neuroplasticity
within the motor system. We additionally examine the extent to which VNS-evoked midbrain activity and
behavioral reinforcement are impacted by known modulators of vagal signaling, including prior exposure to food
and food rewards. To elucidate the mechanisms of VNS-mediated reinforcement, we propose to record neural
activity and optogenetically manipulate dopaminergic signaling in the midbrain during VNS-reinforced behavior.
These studies will provide fundamental insights into the neurobiological mechanisms underlying lateralized vagal
signaling, informing the development of novel VNS strategies for therapeutic modulation of the dopamine system.

Public health relevance
PROJECT NARRATIVE Emerging evidence suggests that activation of ascending projections through the right, but not the left, vagus nerve may activate dopaminergic reward circuits within the central nervous system. These recent findings raise the intriguing possibility that electrical vagus nerve stimulation (VNS) delivered to the right cervical nerve, rather than the traditionally-targeted left cervical nerve, could be used to modulate activity within these reward networks, providing novel strategies for the treatment of movement disorders. To gain further insight into the translational potential of VNS-driven dopaminergic signaling, in the current proposal, we test the neural mechanisms that underlie the neuroplasticity-promoting and behavior-reinforcing properties of VNS, and we examine the extent to which VNS-driven activation of central reward circuits is modified by experience.